IRACDA at the University of Chicago

Enter the text here that is the new abstract information for your application.
The objective of the University of Chicago IRACDA Program is to provide Postdoctoral Scholars recruited to the University of Chicago with a high-quality mentored research experience, as well as the opportunity to gain in-depth teaching experience and training at our partner institutions, Chicago State University and Northeastern Illinois University. Two Scholars per year will be selected, through a formal application process, based on demonstrated commitment to scientific investigation, need for teaching experience and desire for an academic career. Inclusion in the IRACDA and the opportunity to teach will provide a critical impetus in establishing their academic careers by increasing competitiveness for teaching positions. In turn, students at the partner institutions will receive enhanced mentorship and career advice, research opportunities, and improved and expanded curricular offerings, all of which will make them better prepared and more competitive for graduate school. Faculty mentors from the University of Chicago will supervise the research experience, and Teaching mentors from the partner schools will direct their in-depth teaching experience and training at the partner institution. It is anticipated that mentor interactions mediated by Scholars will spawn faculty collaborations as well. In addition, a formal curriculum, based in the Institute for Future Academics, in career-enhancing skills such as grant- writing, communication, lab management, etc., will be provided. The Program and its components will be evaluated with both qualitative and quantitative measures at specific intervals. The ultimate goal is to train a cadre of biomedical and behavioral scientists with both research and teaching skills sufficient to be competitive for academic positions.

Public health relevance
Project Narrative The IRACDA program is an opportunity for University of Chicago postdocs to combine a high-quality research experience with a mentored teaching and training experience at two local partner institutions. Participants will have a Research Mentor at the University of Chicago, where they will develop research-related skills and Teaching Mentors at partner institutions, where they will experience classroom teaching and pedagogical training. Additional didactic activities and training are also part of a specialized curriculum through the Institute for Future Academics.